A Miniaturized and Flexible Continuous Glucose Monitoring Platform

PROJECT SUMMARY
The long-term goal of this project is to develop a scalable, user-friendly, and affordable continuous
glucose monitoring (CGM) system for better diabetes management.
IMS has created the world's smallest electrochemical analyte sensing platform using an application-
specific integrated circuit (ASIC) based on Complementary Metal-Oxide Semiconductor (CMOS)
technology. This design
offers unique advantages,
including extreme
miniaturization, improved
signal-to-noise ratio (SNR)
for better hypoglycemia
accuracy, and on-chip
temperature calibration for
enhanced accuracy and
reliability. The system
employs highly scalable
semiconductor and flexible
electronics manufacturing
methods, increasing lot
sizes by over 1000 times
compared to current
CGMs, simplifying factory calibration, and reducing costs to improve affordability and broaden usage.
We demonstrated the core IMS CGM platform's function in humans through a First-In-Human (FIH)
feasibility study presented at ADA 2023. Recently, we verified the feasibility of the system’s 14-day
operation in an ongoing human study.
Our objective in this grant is to optimize the design by expanding the use of flexible electronics to
create a first-in-class "band-aid" transmitter, as requested by clinical experts and users, to improve
usability and acceptance among minority populations. This new flexible platform is named “GlucoSoft.”
This work is significant as it will enable a fundamental improvement in CGM usability by creating the
first truly flexible "band-aid" transmitter and decreasing costs through a unified fabrication scheme using
flexible electronics for both the in vivo sensor and the skin-worn transmitter. This will be the first ever
CGM with extremely thin and flexible design, hence the reference to “band aid”.
The team includes the original inventors of the core technology from the California Institute of
Technology (Dr. Nazari, Dr. Rahman, Mr. Sencan), a seasoned researcher in electrochemical sensor
technology (Bill Van Antwerp, former CSO of Medtronic MiniMed), regulatory and IP expert (John
Heithaus, JD), commercialization expert (Mr. Paul Strasma, former CEO of Capillary Biomedical),
clinical expert (Dr. Alan Marcus, MD; former Chief Medical Officer of Medtronic Diabetes), and
biosensors and biomaterials expert (Dr. Natalie Wisniewski, Ph.D., former CTO of Profusa, Inc.).

Public health relevance
Project Narrative Despite advancements, continuous glucose monitoring (CGM) remains underutilized by minorities, worsening health outcomes for people with diabetes. Cost and usability are key barriers (prescription bias, limited insurance coverage, bulky transmitters, body image concerns). IMS tackles these issues with the world's smallest, fully integrated CGM. Its core is a miniaturized chip (10x smaller than a rice grain) with three built-in electrochemical sensors and a temperature sensor. The chip is embedded inside a thin, flexible PCB (FPC) filament. A sleek, wearable transmitter powers it and reads data from it via the FPC filament. This user-insertable and user-removable sensor is as thin as a hair and works for 14+ days in the body. Extensive testing (swine and human studies) has validated the system. Now, we propose a groundbreaking, thin and flexible "band-aid" transmitter to replace the current rigid transmitter (all current CGMs use rigid transmitters). This innovative design uses the same fabrication technology (flexible hybrid electronics or flexible electronics for short) for both the sensor and the transmitter, promising lower costs and improved comfort, potentially improving health outcomes for underserved and minority communities.